Preventing Internalizing Psychopathology in Preadolescents Exposed to Chronic Stress

Project Summary/Abstract Not changed by the proposed supplement activities.

Public health relevance
Project Narrative Not changed by the proposed supplement activities.